Cancer Research Training & Education Coordination

The goals of the Cancer Research Training and Education Coordination Core (CRTEC) of Winship Cancer
Institute of Emory University (Winship) are: (1) to provide research training and education opportunities to build
a pipeline of cancer researchers; (2) to ensure their success through mentorship and career development
programs; and (3) to leverage existing programs across Emory University to enhance cancer research training
and education. To facilitate these goals, Winship has made a significant annual investment averaging
$850,000/year during the present funding period in education and training programs. Winship has a longstanding
record of developing and supporting cancer-focused programs for learners from middle school through
graduate school. In addition, through collaborative partnerships, cancer-related training has been incorporated
into training programs across Emory University. CRTEC has facilitated successful submission of F- and Kapplications
from trainees across all four Winship research programs. For post-graduates, Winship career
development activities include support for early career investigators through programs for physician-scientists,
NCI K12 award in Clinical Oncology for physicians, and an American Cancer Society Institutional Research Grant
(ACS-IRG) that includes summer support for undergraduate students and pilot funding for a variety of earlystage
investigators. A pre- submission review process by the Winship Scientific Research Council and Shared
Resource Leaders is in place for trainees and faculty to enhance successful outcomes for grant submissions.
Winship also provides numerous continuing education opportunities for faculty, staff, and clinicians in the
community. As a result of these efforts, 36 trainees across three T32 programs conducted cancer research during
the reporting period. Since 2016, 24 students in Winship member labs received an F31, four received an F30
and 5 received F99 awards. Sixteen out of 17 graduates of the Winship-supported Research Ethics Fellowship
Program proceeded to a career in medicine or research. Taken together, CRTEC promotes high quality cancer
training to develop the next generation of cancer clinicians and researchers to transform cancer research,
prevention, care, and education and reduce the cancer burden in the Winship catchment area.